Center for Access & Delivery Research and Evaluation (CADRE)

CADRE seeks renewed COIN funding to continue to address an HSR&D research emphasis in health care
access and equity while focusing on Secretary Shulkin’s priorities to provide greater choice for Veterans, focus
resources more efficiently, and improve timeliness of services. One-third of all enrolled Veterans are
considered rural. Rural Veterans face unique barriers to care related to shortages of both VHA and community
providers in rural areas, long distances to existing providers, poor availability of broadband internet to support
digital interventions and high rates of poverty. VISN 23 has the highest proportion of rural Veterans, therefore,
CADRE investigators seek to understand access barriers from the rural Veteran’s perspective and develop
interventions that enhance existing VHA and community resources in rural settings. In addition, CADRE aims
to build upon our existing expertise, established operational partnerships and long-term research priorities
through prioritizing five overarching Center goals that align with our focused areas of research and emerging
priorities:
GOAL 1: Improve access to high quality care for rural Veterans through innovative applications of telehealth in
specialty care, community care, and dual use. (Focused Area #1)
GOAL 2: Develop and evaluate interventions targeting the multidrug-resistant organism (MDRO) crisis.
(Focused Area #2)
GOAL 3: Expand our efforts in developing innovative health services research in three emerging areas:
(1) women’s health, (2) epidemic opioid use and substance use disorders, and (3) cardiovascular outcomes.
GOAL 4: Continue the Center’s success in supporting mentored career-development.
GOAL 5: Promote Veteran engagement with recognition that Veterans are experts on Veteran experience.
The proposed focused areas, additional emerging areas and related goals build upon CADRE investigators’
strengths and leverage established partnerships with the Office of Rural Health, Office of Connected Care,
Office of Specialty Care, MDRO Prevention Office, VISN 23, Pharmacy Benefits Management Services, Iowa
City VA Health Care System, the University of Iowa and the Centers for Disease Control & Prevention (CDC).
CADRE investigators have had significant recent accomplishments including: (1) designing and evaluating 2 of
the 5 Office of Rural Health’s Promising Practices; (2) leading a field-based meeting with 37 experts to
establish the national research priorities for MDRO in VA; (3) serving as Senior Reproductive Endocrinologist
and Fertility expert to Women’s Health Service, (4) the making key recommendations to VA leadership
regarding community care, dual use, MDROs, telehealth, and women’s health; and (5) publishing articles that
move their respective fields forward.
CADRE will continue to be led by two accomplished scientists, Eli Perencevich and Heather Reisinger, who’s
leadership in MDRO prevention and rural access provide experience and the necessary connections with VA
operations to continue our success in partner-oriented health services research in the Focused Areas.

Public health relevance
The Center for Access and Delivery Research and Evaluation (CADRE) is seeking to renew its Center of Innovation (COIN) funding to advance research and improve access for Veterans. We aim to build upon our existing expertise, established operational partnerships, and long-term research objectives through prioritizing five overarching goals that align with our focused areas of research and emerging priorities. GOAL 1: Improve access to high quality care for rural Veterans through innovative applications of telehealth in specialty care, community care, and dual use. GOAL 2: Develop and evaluate interventions targeting the multidrug-resistant organism crisis. GOAL 3: Expand efforts in developing innovative health services research in three additional areas: (1) women’s health, (2) epidemic opioid use and substance use disorders, and (3) cardiovascular outcomes. GOAL 4: Continue the Center’s success in supporting mentored career development. GOAL 5: Promote Veteran engagement with recognition that Veterans are experts on Veteran experience.